First stage single-cell brain resource for Alzheimer's disease and related dementias

Last year, we collected over 300 brain samples from the prefrontal cortex of neurologically healthy individuals and generated scATACseq and scRNAseq data. We have successfully processed all prefrontal cortex samples and are working with the CARD Advanced Analytics team to create an automated pipeline to analyze the ATACseq and RNAseq data. This work involved an extensive protocol optimization period, which will be easily applicable to additional brain regions in the future. We have established a collaboration with 10x Genomics, who are sponsoring the processing of an additional 200 substantia nigra samples. We anticipate processing an additional 200 hippocampal samples, with other brain regions possible in the future.

All pipelines developed for this project will be community tools. These pipelines will be packages as a user friendly springboard to growing collaborations with the UKDRI and CZI.